Mitochondrial determinants of monocyte dysfunction in aging

Aging is the primary risk factor for nearly all chronic diseases, and additionally is associated with increased
severity of a number of acute infectious diseases. These phenomena are linked by dysregulation of the innate
immune system, which contributes both to immune dysfunction (immunosenescence) and chronic low-grade
inflammation (inflammaging). Monocytes are key innate immune cells that circulate and release pro-inflammatory
cytokines to contribute to inflammaging, but also have suppressed inflammatory responses upon infectious or
inflammatory challenge in older individuals. Aged monocytes also have aberrant mitochondrial function, but this
observation has not been linked to inflammatory dysfunction, despite the well-known association between
cellular metabolism and immune function.
In this application, we propose in Aim 1 to investigate a metabolic mechanism linking dysfunction of mitochondrial
complex I to impaired inflammatory responses in monocytes from older adults. Additionally, we propose in Aim
2 to utilize a novel mitochondrial transplant procedure to rescue metabolic function in aging, thereby reversing
cellular dysfunction in aged monocytes. We will utilize human and mouse experiments to investigate these
hypotheses.
Results from this study will establish a myeloid cell metabolic pathway which mediates immune dysfunction in
monocytes during aging. Delineation of this pathway could provide new therapeutic targets for treating conditions
associated with inflammaging and/or immunosenescence. As aging is a primary risk factor for many chronic and
infectious diseases, this could have wide-ranging implications. Additionally, we will conduct preclinical testing of
a simple and relatively inexpensive therapy which is cell-type specific and known to be efficacious in regularizing
inflammatory function in myeloid cells in other systems. Results from this study will enhance our understanding
of innate immune dysfunction during aging, leading to new treatments for associated diseases.

Public health relevance
Project Narrative Aging causes both impaired immunity and heightened inflammation, and these are associated with more severe acute and chronic diseases in older populations. The proposed research will define the cellular mechanisms underlying aging-related changes to monocytes, a key innate immune cell, and will characterize a potential therapy to counteract dysfunction in these cells. Findings from this project have implications for the treatment of a variety of infectious and chronic non-infectious diseases in older adults.